CRCNS: Dynamics of thalamocortical networks during sensory discrimination

Thalamocortical networks are critical for basic neural sensory processing and for foundational cognitive
functions such as attention, perception, and working memory. Dysfunction of these networks is thought to
affect symptomology of several neurological disorders and some psychiatric disorders; however, the
dynamics of thalamocortical networks during everyday tasks are poorly understood even in healthy
cognitive function. The thalamus is a complex aggregation of nuclei with distinct roles and connection
patterns. Fundamental questions remain regarding how these many distinct nuclei interact with the
various sensory, motor and association areas in cortex. In particular, the roles of higher-order thalamic
nuclei, each of which projects diffusely across several cortical regions, and the role of the thalamic
reticular nucleus, which inhibits most other thalamic nuclei, remain poorly understood.
In order to clarify the dynamic interactions within thalamocortical networks, this study will measure activity
in all dorsal regions of cortex and in many thalamic nuclei during a variety of sensory discrimination tasks,
similar to those tasks commonly used for studies of cognitive function in health and disease. We will
simulate impairment of several distinct thalamic regions through optogenetic inhibition to elucidate their
roles in comparisons. Next, we will investigate how these dynamic interactions between the thalamic
nuclei and cortical regions develop as animals begin to learn these tasks and as they acquire skilled
performance. A key aspect of our design is that we will carefully monitor spontaneous motions and our
analyses will control for activity in the thalamic nuclei related to these movements, which are often
correlated with cognitive tasks, and would otherwise confound the analyses.
This project will elucidate the roles of the different higher-order thalamic nuclei and of cortical feedback to
these nuclei in gating cognitive processes across several sensory modalities. We expect these findings to
yield many insights about thalamocortical network function during sensory processing, leading to greater
understanding of cognitive function in the animal models used to study neurological and psychiatric
disorders.

Public health relevance
Many neurological disorders, including Parkinson's and Alzheimer’s Diseases impair attention, working memory and other foundational cognitive functions, which are thought to depend upon the interactions between different thalamic nuclei and cortical regions. This study will clarify the interactions among the many distinct cortical and thalamic sub-regions during normal cognitive function, and when some regions are impaired, yielding insights into the brain processes underlying symptoms of many patients.